LOCAL AND SYSTEMIC REGULATION OF BONE DEVELOPMENT

The objective of this project is to investigate local and systemic control of bone development by extracellular matrix components. The experimental model of matrix-induced bone development is the mainstay of this work. Projects currently under study are: 1) Purification and characterization of bone inductive proteins from bovine bone, 2) Monoclonal antibodies to bone inductive proteins, 3) The facture-healing potential of matrix-induced bone, 4) Influence of diabetic bone matrix on bone induction, and 5) Chemotaxis of muscle derived mesenchymal cells to bone inductive proteins.